Environmental triggers of early-onset colorectal cancer: interactions between microplastics and pks+ E coli in early-life gut colonization

SUMMARY
Early-onset colorectal cancer (EOCRC) is rising at an alarming rate and is now the leading cause of cancer-
related deaths in men and the second in women under 50 in the U.S. Despite growing awareness, the
environmental drivers of this trend remain poorly understood. Genomic studies have identified a unique DNA
mutation signature enriched in EOCRC linked to colibactin, a genotoxin produced by E. coli harboring the
polyketide synthase (pks+) gene island. Notably, active pks+ E. coli colonization of tumors is not more common
in EOCRC versus late-onset patients, suggesting that early-life exposure—potentially under conditions that
compromise gut homeostasis—may be a critical risk factor. Micro- and nano-plastics (MNPs), now widespread
in the environment and food chain, are known to disrupt intestinal barrier integrity and induce gut dysbiosis in
animal models. Alarmingly, infants have been shown to carry the highest MNP levels in stool, potentially
rendering them susceptible to early-life pks+ E. coli genotoxicity. We hypothesize that oral MNP exposure
compromises the mucosal barrier of the gut, enabling pks+ E. coli to invade the underlying intestinal
epithelia and induce tumor-initiating DNA mutations. In our preliminary studies, chronic MNP exposure in
mice led to enlarged lymphoid aggregates in the colon and enhanced tumor burden in a chemical
carcinogenesis model. These findings support the need to examine whether MNPs contribute to EOCRC
initiation by facilitating genotoxic microbial invasion.
Aim 1 will test whether MNPs potentiate epithelial invasion by pks+ E. coli in vivo. Mice will receive oral
gavage of pks+ E. coli (with and without prior antibiotic suppression of the microbiome) followed by short-term
and chronic MNP exposure in the drinking water, using a novel MNP formulation we have developed and
previously tested in mice. Bacterial invasion will be assessed via quantitative PCR and RNA in situ
hybridization. Aim 2 will test whether MNPs potentiate epithelial mutagenesis by pks+ E. coli in vivo. DNA from
intestinal tissue in Aim 1 will be isolated and mutational signatures evaluated using ultradeep error-corrected
sequencing of a custom hybrid-capture panel of CRC “driver” genes. High sequencing accuracy and depth will
enable us to confidently call rare colibactin-induced mutations in the normal intestine.
This pilot study leverages our institutional expertise in microbiome research and mouse models of mutagenic
processes, as well as our preliminary data supporting MNP-driven immune disruption in the gut. This work will
generate foundational evidence linking MNPs to bacterial genotoxicity and EOCRC risk, laying the groundwork
for an R01. Our results will also provide proof-of-concept for feasibility of new screening approaches aimed at
detecting mutational signatures that predict cancer risk in healthy individuals. Such future strategies, if
successful, could scale to the entire population for early-life non-invasive screening to prevent EOCRC.

Public health relevance
NARRATIVE Early-onset colorectal cancer (EOCRC) is increasing globally, yet its environmental causes remain unclear. This pilot project investigates how exposure to micro- and nano-plastics (MNPs) may promote gut colonization and DNA damage by cancer-associated pks⁺ E. coli, uncovering a potential early-life risk factor for EOCRC. Findings may inform prevention strategies, public health policy, and cancer screening in young populations.